Therapeutic implications of purinergic receptor P2X4 in ischemic stroke

Summary:
Stroke remains a leading cause of disability in the United States. Stroke is a heterogeneous multifactorial
disorder. Prior attempts at developing new therapies have failed in clinics due to imperfect target validation,
unrealistic therapeutic windows and lack of age appropriate models. Thus, there is an opportunity and a need
to identify new medical treatment for stroke. The immune cells move to stroke area in the brain and contribute
to damage. We have recently shown that the purinergic P2X4 receptor is excessively stimulated by adenosine
triphosphate (ATP) released by dying brain cells during stroke. This receptor protein then causes activation of
the immune cells and results in greater stroke injury. We have assembled the necessary tools such as animals
lacking P2X4 receptors as well as blockers that selectively inhibit the receptor. The proposal, using these new
tools, aims to investigate whether this receptor protein is a novel target to develop treatment for subjects with
stroke. Our initial data suggest that blocking or deleting this receptor protein during the acute phase of stroke is
beneficial. However, it is unknown how this protein works and what its potential adverse effects might be.
Answering these questions is the overall goal here and should define the correct approach in pursuing a new
stroke treatment

Public health relevance
Narratives: Stroke remains a leading cause of disability in the United States. Despite recent advances, interventions to reduce damage and enhance recovery after stroke are absent. In this proposal we will investigate a novel drug target “Purinergic receptor P2X4” for the treatment of ischemic stroke in mice. The overall goal of this proposal is to determine if reduction of acute P2X4R response is a viable therapy for stroke in elderly, working towards our long-term goal of developing and identifying target-based therapies for stroke.